Effects of Light at Night and Disrupted Circadian Rhythms on Pain

Abstract
Widespread adoption of electric lighting has led to significant exposure to artificial light at night (LAN).
Although initially assumed innocuous, exposure to LAN disrupts circadian rhythms and is correlated with
increased prevalence of several clinical disorders. This so-called light pollution began prior to a deep
appreciation of the importance of circadian rhythms to typical, adaptive functioning. Our preliminary data
indicate that exposure to LAN disrupts circadian rhythms, dramatically increases peripheral and central
inflammation, and elevates pain responsiveness in mice. Pain is a significant cause of high medical costs,
lost productivity, and a common pathway to opiate addiction. Currently, there are few optimal treatments for
chronic pain and the underlying causes, and predictive factors that lead individuals from therapeutic use to
opiate abuse remain unspecified. Pain responsiveness shows daily variation with elevated responses at
night. We hypothesize that disrupted circadian rhythms, caused by exposure to LAN, drive inflammatory
processes and influence pain responsiveness. We will test this hypothesis and predict that mice exposed to
dim light at night (dLAN) will display elevated pain responsiveness. We further hypothesize that circadian
responses to opiate management of pain are deranged by light at night. Thus, we predict that higher doses
of opiates are required to obtain similar suppression of pain responses in animals exposed to dim light at
night. These hypotheses will be tested in two specific aims. In the first specific aim, we will characterize the
effects of dLAN exposure on pain responsiveness in mice. Because of the well-known sex differences in
pain responsiveness, we will test both male and female mice in pain responsiveness after exposure to
dLAN. Circadian clocks are entrained by light interacting with melanopsin-expressing retinal ganglion cells
which are primarily responsive to short-wavelength (blue) light, and relatively unresponsive to long
wavelength (red) light. Thus, we will examine pain responsiveness after exposure to dark, dim white, dim
blue, or dim red light at night to test the hypothesis that exposure to dLAN comprised of wavelengths that
affect circadian clock entrainment (white and blue) will elevate pain responsiveness, whereas exposure to
dark nights or dim red light at night prevents elevated pain responsiveness. Specific Aim 2 will test the
hypothesis that disruption of circadian organization by exposure to dLAN changes sensitivity/
responsiveness to opiates. We predict that dose responses to opiates will shift so that increased opiate
dosages will be required to suppress pain responses. Taken together, the results of this project will fill an
important gap in knowledge about the role of circadian rhythms in pain responses and pain treatment. If our
hypotheses are not disproved, then these results could easily and inexpensively be translated to individuals
suffering from pain—e.g., blue-light blocking goggles or other environmental lighting adjustments—to align
circadian rhythms, to improve pain treatment outcomes, and avoid opiate abuse.

Public health relevance
PROJECT NARRATIVE Around the clock exposure to light has long been considered an innocuous consequence of industrialization and modernization. To the contrary, there is now accumulating epidemiological data suggesting that exposure to light at night can cause circadian rhythm disruption, which could alter intrinsic circadian rhythms of pain responsiveness and exacerbate experiences of painful stimuli. Our goal is to use mice to determine how light at night alters pain responsiveness and sensitivity to discover whether changes in environmental lighting at night can prevent or ameliorate elevated pain responses.